Replacement and enhancement of Cell Sorting capabilities at UCSC

PROJECT SUMMARY/ABSTRACT
Established in 2007, the Flow Cytometry Core facility serves all research programs and faculty within
the Physical and Biological Sciences division and the division of Engineering. It allows access to high-speed
flow cytometry-based analysis and cell sorting of dissociated cell populations from human samples, animal
experiments, and cell culture studies. The UCSC Cytometry Core is a highly utilized facility that has been
critical to all research within the two divisions mentioned above. Our current sorter, a BD FACS Aria II, is over
17 years old and BD will no longer support the service contract for this machine starting 2025. In addition,
recent advances in FACS technology have rendered it incapable of meeting state-of-the-art research needs.
This threatens to limit critical advances in research.
To address these challenges the senior leadership across our two divisions have developed a
comprehensive plan to revitalize the UCSC Cytometry Core. The plan involves acquiring the BD
FACSymphony™ S6 high parameter cell sorter, a bench-top high-speed cell sorter equipped with five lasers
capable of analyzing up to 21 different colors plus forward and side scatter. The
BD FACSymphony™ S6 will
be contained within a biosafety cabinet to meet safety and regulatory requirements for sorting clinical samples.
The
BD FACSymphony™ S6 cell sorter represents a crucial early step in advancing the senior leaders' vision
to modernize the Cytometry Core. This instrument will ensure that researchers at UCSC have access to the
cell sorting technology they need to carry out high-impact funded research 24 hours a day, 7 days a week, 365
days a year.
Without this instrument, the Cytometry Core will be unable to offer cell sorting, and the closest cell
sorters available to the campus are over an hour away with very limited availability. Acquisition of the BD
FACSymphony™ S6 cell sorter is therefore essential to continuing high-impact NIH-funded research at UCSC.
Instrument supervision, training, maintenance scheduling, and recharge accounting for use of the proposed
instrument will be assured by the Cytometry Core Facility manager and guided by an Advisory Committee. The
core facility manager's salary and instrument operation and maintenance costs have historically been
guaranteed by UCSC and will continue to be backed by UCSC for at least 5 years after the purchase of this
instrument.

Public health relevance
Narrative UCSC proposes to purchase a BD FACSymphony™ S6 cell sorter with 5 lasers (UV, violet, blue, yellow and red) and 23 detectors to replace our aging BD FACS Aria II. The proposed BD FACSymphony™ S6 will be UCSC's only flow cytometry assisted sorter. The capabilities of the new BD FACSymphony™ S6 will significantly expand the use of flow cytometric analysis and sorting and allow for more efficient processing as well as an ability to isolate rare cell populations at BSL2 safety levels.